FASEB SRC: The Folate, Vitamin B12, and One-Carbon Metabolism Conference

The biennial conference entitled “Folate, Vitamin B12 and One-Carbon Metabolism” will be held at the
Renaissance Hotel in Asheville, NC, August 14-19, 2022. This conference, which is part of the Federation of
American Societies for Experimental Biology (FASEB) Summer Research Conference (SRC) series has been
convened every two years since its inception in 1986. The philosophy of the conference is to bring together basic
researchers, clinicians, and public health experts to present and discuss the latest developments related to B
vitamins and one-carbon metabolism. The conference is typically attended by the most prominent experts in the
field from around the world, as well as young investigators completing their doctoral and postdoctoral studies.
The Specific Aims of the conference are to: 1) convene world experts and trainees in the area of B vitamins
and one-carbon metabolism to present and discuss the latest, cutting edge research, emphasizing unpublished
data; 2) provide opportunities for trainees and investigators new to this meeting to present their work, receive
feedback from established investigators in the field, and develop collaborations and professional connections;
and 3) promote attendance at the conference by providing travel funding for invited speakers and awarding travel
prizes to graduate and postdoctoral trainees for outstanding oral and poster presentations. Funds are allocated
to enhance attendance by under-represented minorities and to enhance their active participation. Scientific
highlights of the 2022 meeting include sessions on: 1) 1-carbon nutrients, their metabolism, and cancer, 2) the
roles of the microbiome in 1-carbon metabolism, 3) basic aspects of one-carbon metabolism and their clinical
implications, 4) the role of 1-carbon nutrients and their metabolism in chronic disease, 5) hereditary disorders of
1-carbon metabolism, 6) the updates required for the Dietary Recommended Intakes (DRIs) of 1-carbon nutrients
(a workshop format), 7) potential adverse effects of excess intake of folic acid: an ongoing controversy, 8) the
relationship between 1-carbon metabolism and maternal and offspring health, and 9) the idiosyncratic
dependence of methionine by cancer cells.
The specific aims will be achieved through 10 sessions consisting of oral presentations from invited speakers
(30 minute talks) and from selected abstracts submitted to the conference (15 minute talks; expanding
opportunities for trainees to give oral presentations), two poster sessions (2 hours each), and two ‘meet-the-
expert/career development’ sessions in which trainees and young investigators will meet with senior investigators
to discuss research and professional development. There also will be ample opportunities for informal
interactions among the participants during meals, breaks, poster sessions, and outdoor recreational activities.
These interactions will catalyze new research directions and collaborations, promote the professional
development of young investigators, and invigorate the future of the field.

Public health relevance
PROJECT NARRATIVE This proposal requests partial funding of the FASEB SRC on Folate, Vitamin B12 and One-Carbon Metabolism to be held at the Renaissance Hotel in Asheville, N. Carolina August 14-19, 2022. The goals are to convene world experts and trainees in the area of B vitamins and one-carbon metabolism to present and discuss the latest, cutting edge research and implications for public health, to assist in the advance of the careers of junior investigators, and to encourage participation of under-represented minorities. The conference provides important educational and networking opportunities for the many junior investigators and trainees who attend the meeting, including opportunities to present their latest research.